The impact of alcohol and its metabolites on the epigenome of astrocytes

PROJECT SUMMARY
Alcohol use disorder (AUD) is a global disease burden and while biological mechanisms underlying AUD have
largely been examined in neurons, the role of glial cells is historically understudied. One glial cell type potentially
important in AUD is astrocytes, which undergo transcriptional and functional changes upon alcohol exposure.
Knowledge of how this is regulated is limited. Since astrocytes are the most abundant glial cell type in the central
nervous system (CNS) and dynamically modulate neuronal activity and synaptic plasticity, it is conceivable that
the impact of ethanol (EtOH) and its metabolite acetate on astrocytes may lead to both pronounced intracellular
effects and subsequent downstream effects on the CNS through epigenetic mechanisms. In support of this notion,
acetyl-CoA synthetase 2 (ACSS2) converts acetate to acetyl-CoA used in chromatin regulation of gene
expression. Acetyl-CoA is used by histone acetyltransferases (HATs) to drive histone acetylation, which is
associated with active transcription and is thought to underlie alcohol-related behaviours. However, whether
acetate contributes to histone acetylation specifically in astrocytes, and whether this process is mediated by
ACSS2, is unknown. Our lab has previously shown that EtOH is metabolized and deposited as acetate in the
brain. During my preliminary studies, I found ACSS2 is highly expressed in and localized to the nucleus of
astrocytes, suggesting an epigenetic, gene regulatory role. Treating primary astrocytes with acetate for 24 hours
induced differential regulation of over 800 genes by RNA-seq. Moreover, an ACSS2 inhibitor reduced certain
acetate-induced transcriptional effects. Interestingly, treating astrocytes with acetate for only 1 hour increased
immediate early gene (IEG) expression, although this was not identified at 24 hours. This suggests astrocytes
induce distinct waves of gene expression, which has never been directly tested in astrocytes but can importantly
contribute to neuronal activity. Spatial transcriptomics analysis in vivo agrees with this, as stimulating fear
memories in mice led to astrocytes upregulating certain IEGs at an early time point. Strikingly, this upregulation
did not occur in full-body ACSS2 knockout mice. Based on the these evidence and models, I hypothesize that
alcohol and its metabolites stimulate waves of transcription in astrocytes, where ACSS2 incorporates
acetate into histone acetylation to activate genes that promote alcohol-associated behaviours. To
address this hypothesis, I propose to focus on two specific aims: (1) to determine the wave-trajectory of astrocyte
gene expression and the impact of alcohol and its metabolites, and (2) to determine whether astrocytes in the
brain respond to alcohol metabolism by incorporating alcohol-derived acetate into histone acetylation at key DNA
regulatory regions. Completion of these aims will not only reveal potential new therapeutic targets for AUD but
will also unveil the capability and mechanism of astrocytes undergoing wave-trajectory of gene expression, yet
to be studied. Notably, my study is different from my supervisor’s current NIAAA R01 submission under review.

Public health relevance
PROJECT NARRATIVE Astrocytes are the most abundant glial cell type and have many critical functions in the brain, yet their role in alcohol use disorder (AUD) remains largely understudied. While astrocytes are highly sensitive to alcohol- induced transcriptional and functional alterations, deeper knowledge of the mechanisms underlying these changes is required to further elucidate astrocyte contributions to alcohol-associated behaviors. Our work will rigorously interrogate the impact of alcohol and acetate on astrocyte transcription by focusing on ACSS2- associated epigenetic mechanisms, with broader implications of this mechanism on alcohol-associated behaviors, to reveal potential new therapeutic targets against AUD.